Selective C(sp3)–H Functionalization Enabled by Metal-Organic Framework Catalysis

PROJECT SUMMARY/ABSTRACT
Despite decades of research dedicated to expanding the structural complexity accessible to medicinal chemists,
organic synthesis remains a time- and resource-intensive component of drug-discovery. To address this
challenge, synthetic organic chemists have focused on inventing new methodologies to couple widely available
building blocks into drug-like products, expanding the range of bioactive compounds directly accessible from
simple precursors. Relatively few studies, however, have focused instead on increasing the diversity and
complexity of those readily accessible precursors. As a small number of privileged reactions represent the
majority of synthetic steps conducted within drug discovery, providing access to a broad range of building blocks
for such transformations could dramatically expand accessible chemical space for medicinal chemists. Towards
this end, methods for the functionalization of C–H bonds have the potential to revolutionize the synthesis of
pharmaceutically relevant fragments by enabling the introduction of valuable functionality at ubiquitous but
traditionally unreactive sites. Unfortunately, due to the abundance of C–H bonds, this approach often suffers
from poor selectivity, resulting in challenging purifications of isomers and diminished yields. As a general strategy
to facilitate selective C–H functionalization, the proposed research will leverage the remarkable properties of
metal-organic frameworks (MOFs), which can both selectively bind small organic molecules and stabilize highly
reactive species capable of cleaving C(sp3)–H bonds. By holding specific C–H bonds near the site of reactivity,
selectivity based on the binding pose of the substrate within the MOF pore—not the inherent reactivity of each
C–H bond—can determine the functionalized position. Employing MOFs capable of supporting metal-oxo
species with substrate-binding linkers or, alternatively, MOFs bearing photocatalytic linkers with nodes
containing open coordination sites provides two distinct approaches to realize this aim. Combining selective
radical generation with established open-shell reactivity can afford a diverse range of products such as halides,
boronic esters, and C–C bonds via Minisci and Giese reactivity. Overall, the proposed research will provide a
novel approach to the long-standing challenge of selective C(sp3)–H functionalization, enabling the efficient
conversion of simple starting materials into valuable fragments for use in drug discovery. Conducting this
research will provide thorough training in the experimental methods required to synthesize and characterize
inorganic materials, including PXRD, ICP-MS, gas adsorption, and photophysical techniques. Massachusetts
Institute of Technology, as one of the largest and most productive scientific research institutions in the world,
possesses the facilities and institutional environment required to support these studies.

Public health relevance
PROJECT NARRATIVE The direct functionalization of aliphatic C–H bonds has the potential to revolutionize the synthesis of organic molecules within drug discovery, but its value remains limited by difficulties differentiating between the large numbers of similar C–H bonds present in pharmaceutically relevant structures. This proposal aims to develop a new approach to site-selective C(sp3)–H functionalization, leveraging the selective binding of organic molecules to metal-organic frameworks to position specific C–H bonds near reactive species capable of cleaving them. Combining selective radical generation with established radical reactivity should enable the rapid conversion of abundant feedstocks into pharmaceutical building blocks, expanding accessible chemical space for medicinal chemistry.